EFFECT OF CORNEAL ENDOTHELIAL MORPHOLOGIC ABNORMALITIES ON CORNEAL HYDRATION

To measure the rate of recovery from induced stromal swelling and the endothelial permeability to fluorescein in three conditions with endothelial morphologic abnormalities: poorly controlled diabetes mellitus, long-term contact lens wear, and long-term corneal transplants.